Data Analysis Core

Project Summary, Data Analysis Core
The Data Analysis Core provides end-to-end experimental and computational expertise: initial experimental
design and power studies, ongoing data generation and analysis, and ultimate data deposition and sharing. The
Data Analysis Core will support high-dimensional data generation and analysis for the Organ Specific Project,
including multi-omics data integration methods at distinct biological scales. This Core will collaborate closely with
the HuBMAP HIVE to harmonize data and pipelines to enable meta-analyses across tissues. Core Leaders will
participate in the monthly Center Executive Committee meetings with the Organ Specific Project Lead and
Consortium meetings to ensure ample experimental support and computational resources for new research
directions and collaborations with HuBMAP. The Core will have a designated Project Manager and Data Manager
to assist with data standards and harmonization, data validation, data wrangling, and overall data deposition,
data and software sharing, and genomic data sharing with the HIVE. In summary, the Data Analysis Core will
support the overall research objectives by providing robust, reproducible experimental protocols and
computational methods to characterize the impact of skin location, sex, race, and aging on the cellular and
molecular changes to skin; to analyze spatial and temporal data to infer interactions and crosstalk between cell
types; and to integrate our atlas of three-dimensional multi-omics skin datasets with the HIVE to promote cross-
tissue analyses in the HuBMAP Consortium.